Candida-Host interactions: impact on the host pro- and anti-viral restrictions factors

The human immunodeficiency virus (HIV) is responsible for the acquired immunodeficiency syndrome (AIDS).
The first cases of AIDS were reported in 1981 and it is one of the world's most serious health problems. The risk
of adults becoming infected through the oral route appears to be relatively low and it is generally assumed that
HIV transmission does not occur through casual oral contact, even among patients with high viral load. People
with advanced HIV infection are vulnerable to life-threatening malignancies and opportunistic infections such
as candidiasis. Oropharyngeal candidiasis affects up to 50% of untreated HIV-1 subjects and 90% of AIDS
patients. Interestingly, HIV-1 directly interacts with Candida spp and this interaction abrogates the production
of HIV-1 by infected macrophages. Our preliminary data provide new insights into the mechanisms by which
Candida albicans acts against HIV-1. The putative pathways by which C. albicans affects HIV-1 infection
involve the upregulation of cc-chemokines. Therefore, the hypothesis of the proposed study is that C. albicans
are involved in the inhibition of HIV pathogenesis. To explore our hypothesis, we propose to: 1) Elucidate the
specific host cell-signaling pathways induced by C. albicans PAMPs relevant to production of anti-HIV cc-chemokines and 2) Determine how C. albicans PAMPs driven responses impact the host antiviral restrictions
factors.

Public health relevance
HIV replication, continued cellular reinfection, and persistence is dependent on the regulation of transcription factors and anti-viral restriction factors associated with target cell activation and the cytokine microenvironment. Understanding the effects of oral Candida spp on HIV pathogenesis will establish a means by which the mycobiome contributes to the modulation of host viral restriction factors. Data from the R03 will provide rationale and direction for the design interventions to improve the quality of life of people living with HIV.